Elucidating impacts of genetic variability of Bifidobacterium strains on preterm infant gut immune responses

Project Summary/Abstract
The gastrointestinal tract of preterm infants plays a major role in overall infant nutrition, growth, and health.
Increasing interest by clinicians and researchers has uncovered relationships between the gut microbiome and
many of the primary causes of morbidity and mortality in preterm infants. To address these risks from the gut
microbiome, probiotics are an attractive and translatable approach to remodel the infant gut microbiome.
However, there is a strong need to understand the mechanism by which probiotic organisms act on the
preterm gut and with the gut ecosystem in order to guide the rational selection of probiotic organisms for use in
this patient population. In particular, there is a current lack of understanding as to how genomic variation
among probiotic organisms may, or may not, influence their relative efficacy and/or safety in vivo. The
proposed studies begin to address these issues by (1) examining the impact of genomic variations within a well
characterized infant gut symbiont, and frequent probiotic organism, B. infantis, on ecological performance in in
vitro competition models and then (2) how these variations affect the preterm gut epithelium in an epithelial cell
line that closely mimics the cells found in the preterm infant gut. Together, these experiments seek to
understand how diet (i.e. human milk), a probiotic gut symbiont (B. infantis), and the preterm host interact in
terms of both transcriptional responses and host immune, proliferative, and necroptotic responses.

Public health relevance
Project Narrative Probiotics are a conceptually attractive approach to modify the gut microbiome of preterm infants, given that the primary causes of morbidity and mortality in these patients are related to inflammation and infection originating in the gut microbiome. The proposed studies examine how genetic differences between strains of a single probiotic organism, Bifidobacterium longum subsp. infantis, impact qualities relevant to the preterm infant gut microbiome and patient outcomes. We will examine how genetic differences in key gene clusters alter substrate (i.e. human milk oligosaccharide) utilization and ecological performance of these strains in competition models, how these differences affect transcriptomic responses to these substrates, and evaluate how strain-level differences impact intestinal epithelial cell responses to Bifidobacterium longum subsp. infantis.